Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
The Administrative Core for the proposed renewal of our NEI Center Core Grant for Vision Research
(P30) will continue to function to coordinate the overall functioning of each of the individual core
modules (Microscopy and Imaging, Drug Delivery and Nanotechnology, Animal Models,
Bioinformatics, and Biostatistics). The responsibilities of the administrative core span the range of all
activities of the P30 program, including working with core module directors to optimize and modify
research program activities as needed, supervising budgets, insuring smooth functioning of the cores
and prioritization of NEI R01 funded research projects, helping with regulatory and administrative
issue, and dealing with any personnel or other challenges that develop. These functions will be
accomplished through periodic and regular meetings with module directors and core users. In an
effort to further expand and facillitate these efforts, we have recently developed an online survey
mechanism to provide rapid and comprehensive feedback and also are expanding the Core's
website.